P30 Wilmer Core Grant for Vision Research

PROJECT SUMMARY The Wilmer Eye Institute is one of the world leaders in vision research. Our research programs range from basic/fundamental studies on the mechanisms of eye development and vision, to studies of the genetics and pathogenesis of eye disease, to translational studies, to clinical trials, to epidemiological and international studies of the worldwide causes of vision loss and disability. Wilmer has been fortunate to have been funded through an NEI Core Grant for Vision Research for over forty years, and this funding has provided the infrastructure and core support for a wide variety of these studies. The support that the Core grant has provided has been a tremendous aid in facilitating Wilmer's diverse research programs and it has also encouraged numerous collaborative research projects. In this competitive renewal application, we are seeking support to continue these essential infrastructure and core activities. We are proposing both continuation of past services, but also modifying and updating some cores so as to better adapt to changing research needs, technologies, and priorities. The modules for which funding is requested are cores for Imaging and Microscopy, Biostatistics, Bioinformatics, Animal Modeling, and Drug Delivery and Nanotechnology. We feel that this module structure, together with a rigorous administration support structure, will best serve and facilitate the diverse vision research activities at Wilmer and throughout Johns Hopkins.

Public health relevance
PROJECT NARRATIVE Our NEI Core Grant for Vision Research (P30) research plan is designed to support and facilitate the success and productivity of the many and diverse vision research programs at The Wilmer Eye Institute and throughout Johns Hopkins, and also to encourage collaborative, innovative, and multi-disciplinary research studies.